In vivo PET imaging of novel engineered AAVs informs capsid design in Alzheimer's Disease

Abstract of proposed Alzheimer’s disease-related supplement
In 2021, Alzheimer’s disease (AD) affects more than 20 million people worldwide, with about 135 million people
expected to develop AD by 2050 and 3.3% of the US population by 2060. Our goal in this supplement is to
apply the positron emission tomography (PET) tools developed in the parent grant to the assessment of gene
delivery in AD. Adeno-associated viruses (AAVs) are a promising tool and can be used to encode for growth
factors, hormones, Cdk5 inhibitors, transcription factors, immune factors, modulators of Aβ metabolism, tumor
necrosis factor, synaptic function mediators, neural function mediators, or age suppressing factors in the
treatment of AD. In addition, AAVs have the potential to enable gene editing. Here, we specifically will deliver
genes encoding reporters or brain-derived neurotropic factor (BDNF) in an AAV. BDNF was selected for this
proof of concept study due to the first-in-human study in AD (NCT05040217) that has recently begun based
on stereotactic AAV injection. Delivery of gene and protein therapy to the brain has traditionally been extremely
limited but may be further limited in AD. Autoimmune neurological diseases are often linked to a dysfunctional
BBB. With neuroinflammation, reactive oxygen species (ROS) generation can disrupt the BBB via various
mechanisms. BBB dysfunction is hypothesized to play a role in AD pathology as a result of impaired P-
glycoprotein mediated efflux from the brain or reduced LRP1 expression and resulting reduced transport of Aβ
across the BBB. Using a directed evolution approach to viral capsid engineering and selection, the Gradinaru
group at Caltech identified specific peptides that, when displayed on the surface of modified capsids, enhanced
BBB transport and neuronal transduction compared to the conventionally-used adeno-associated virus AAV9,
following intravenous (IV) injection in mice. We developed novel combined positron emission tomography
(PET) imaging techniques that non-invasively assess the pharmacokinetics of the AAV over the first days after
injection and the resulting gene expression over months or potentially years. For gene transduction reporting,
we include the pyruvate kinase M2 (PKM2) reporter gene which has a low background level in the brain and is
imaged with [18F]DASA-23, a tracer that freely crosses the BBB. The brain uptake of these novel AAVs studied
here by PET imaging reaches an extraordinary temporal-peak spatial-maximum of ~35% ID/cc at 4 h post-
injection in mouse models. Recent selections at Caltech have provided additional capsids that transduce the
mouse and primate brain with reduced expression in the liver, spleen, kidneys, and lungs. Our resulting
specific aims are to: 1. Validate and apply PET imaging techniques to assess brain delivery of a radioactive tag
and reporter gene in mouse models of AD using both traditional and novel AAV capsids, and 2. Evaluate
BDNF protein production as a result of AAV delivery to the brain in WT and mouse models of AD based on
systemic injection with and without BBB opening. Both the traditional AAV2 and novel AAV capsids (e.g.
AAV.CAP-B10) will be tagged and PET imaging used to assess delivery and protein level.

Public health relevance
Narrative This proposal seeks to determine whether novel AAV capsids can deliver gene therapy in mouse models of Alzheimer’s disease. We develop the novel imaging methods required to quantify delivery.